TRACER KINETIC STUDIES, GALACTOSE METABOLISM--PATIENT W/ HEREDITARY GALACTOSEMIA

This study will measure Galactose metabolism in both patients with galactosemia and normal controls. Various drugs will be tested to determine their effect on galactose oxidation rate and pool size.